OD NOURISH AUTOIMMUNITY CHALLENGE INITIAL OBLIG

The NOURISH (Nutrition for OUR Immune System Health): Autoimmunity Challenge is a crowdsourcing competition focused on generating a cadre of innovative ideas on how to best integrate diet and nutrition studies into autoimmune disease research with a focus on identifying dietary interventions that are feasible, testable, scalable, and will have broad impact across the broad autoimmune disease portfolio.